Shared Resource: Cellular Imaging

PROJECT SUMMARY: CELLULAR IMAGING SHARED RESOURCE (CISR)
The Cellular Imaging Shared Resource (CISR) provides support with a broad range of advanced imaging and
quantitative image analysis technologies for probing the structure and function of cells and model organisms
from the molecular to the cellular level. Supported applications include scanning and transmission electron
microscopy, electron microscopy (EM) sample preparation, transmitted light and fluorescence microscopy
modalities (including confocal, deconvolution, total internal reflection fluorescence microscopy (TIRF), super-
resolution, time-lapse, whole slide scanning, and high-content screening), and live image-based cellular
assays recently implemented to support the growing Cancer Immunology Research Program. Additional
services include quantitative gel and blot analysis as well as karyotyping. CISR is under the leadership of Dr.
Julio Vazquez who is assisted by two staff members (1.65 FTE) and one external consultant.
For the period 2015-2018, CISR provided services to more than 500 individual users from approximately 150
research groups representing all of the Consortium’s Research Programs. In FY 2018 alone, CISR supported
over 200 research grants. CISR has introduced many new technologies to the Consortium, supports and
accelerates cancer research by providing leading edge instrumentation and expertise, training users new to
each technique, and working closely with researchers in all supported technologies. While many labs have
their own instruments for routine work, many advanced technologies are only available in the CISR.
1

Public health relevance
Not applicable to P30 CCSG as stated in the FOA PAR-17-095.